Coordination Core

PROJECT SUMMARY – Coordination Core. The proposed multidisciplinary Eye and Pancreas Tissue Mapping
Center (TMC) for the Human BioMolecular Atlas Program (HuBMAP) requires diverse proficiencies including (1)
the biological expertise and infrastructure required for acquisition of normal human tissue, (2) the analytical skills
to produce highly multiplexed multimodal molecular imaging data, (3) computational expertise in integrating and
mining complex data, and (4) a track record in collaboration between the TMC components and other HuBMAP
consortium members. The Coordination Core (CC) will be a key center of administration for the proposed
Vanderbilt University Eye and Pancreas Tissue Mapping Center (TMC). The specific aims of the CC directly
reflect its role to prioritize achievement of program milestones through effective leadership, sharing of data and
samples, and communication with HuBMAP leadership as well as interaction among Consortium groups to
provide a foundation of success for the Vanderbilt Eye and Pancreas TMC. Leadership for the proposed TMC
include distinguished experts in their fields: Dr. Jeffrey Spraggins (MPI, BIOMIC Director, DAC Team Leader),
Dr. Richard Caprioli (MPI, CC Team Leader), Dr. Alvin Powers (MPI, Pancreas OSP Team Leader), and Dr.
Kevin Schey (MPI, Eye OSP co-Team Leader). These four have worked extensively together in rigorous and
large-scale research programs, for which they have managed research activities, collaborations, and data
coordination. To contribute productively to the HuBMAP consortium, the proposed Vanderbilt Eye and
Pancreas TMC will share and accept protocols, samples, and data to promote and unify 3-D molecular atlas
construction across the Consortium. The Vanderbilt team will follow and participate in the development of policies
and procedures established by the Consortium, including those for data/specimen sharing and publications. The
overall mission of the CC and for the proposed TMC is to successfully contribute to HuBMAP to establish 3-D
molecular human tissue atlases that advance biomedical research.